Is Aspirin a Cost-Effective Thromboprophylaxis Alternative for Orthopaedic Trauma Patients?

ABSTRACT
Orthopaedic trauma affects 1 million Americans annually and is a strong risk factor for venous
thromboembolism (VTE) due to the initial injury, surgical intervention, and postoperative immobilization. The
treatment of VTE, which includes deep vein thrombosis (DVT) and pulmonary embolism (PE), is associated
with costly medical interventions, extended inpatient duration, hospital readmission, and high fatality rates.
Currently, all major clinical guidelines recommend a multiweek course of low-molecular-weight heparin
(LMWH, enoxaparin) to prevent VTE after orthopaedic trauma. However, our study team recently published a
trial in the New England Journal of Medicine that compared thromboprophylaxis with LMWH versus aspirin in
over 12,000 patients who sustained orthopaedic trauma. We found that aspirin was noninferior to LMWH in
preventing fatal events and similar in its protection against PE and major bleeding events. In contrast, LMWH
provided better protection against DVT. Given the substantially lower cost of aspirin for thromboprophylaxis
compared to LMWH, determining if LMWH or aspirin is more cost-effective is of tremendous interest to
patients, clinicians, payers, and policymakers. In this proposed study, we aim to 1) generate evidence on the
comparative costs and effects of LMWH versus aspirin for the prevention of VTE after orthopaedic
trauma and 2) determine the cost-effectiveness of LMWH versus aspirin for thromboprophylaxis in
orthopaedic trauma patients. We will combine clinical trial data of over 12,000 patients with Truven
MarketScan and federal drug pricing data to estimate intervention and treatment costs. In addition, we will
estimate health state utilities (HSU) of discrete health states associated with our study outcomes (death, PE,
DVT, bleeding) through a systematic literature review of clinical studies with health-related quality of life data.
With these data, we will perform a cost-utility analysis (CUA), based on a de novo Markov model, from the US
healthcare sector payers’ perspectives. In addition to a base model, we will explore heterogeneity through
subgroup estimates based on policy-relevant indicators (age, insurance status, VTE risk, and race). In all
models, we will compute the total costs and QALYs expected from each treatment and subgroup. With these,
incremental cost-effectiveness ratios (ICERs) of LMWH compared to aspirin using total costs and QALYs
accumulated from each treatment. In the base case, we will compare the computed ICER to a standard
willingness to pay (WTP) threshold of $100,000 per QALY to assess cost-effectiveness. We will also estimate
the value-based prices of LMWH to discern the difference between current market prices and value-based
prices at various WTP thresholds. The proposed research is directly relevant to improving patient safety and
making healthcare more affordable.

Public health relevance
PROJECT NARRATIVE Preventing venous thromboembolism (VTE), particularly in high-risk patients such as those who sustain orthopaedic trauma, is a critical quality and patient safety issue. Current clinical guidelines recommend a multiweek course of low-molecular-weight heparin (LMWH) to prevent VTE after orthopaedic trauma; however, our research team recently published a 12,000-patient clinical trial which suggests aspirin yields similar protection against fatal events and pulmonary embolism but not deep vein thrombosis. This proposed research will combine this new, high-quality trial data with existing cost databases to determine if LMWH or aspirin is more cost-effective for the 1 million Americans who suffer orthopaedic trauma each year.